Regulation of Hormone Resistant Breast Cancer by IGF and Insulin System

Both effective and tolerable, hormonal agents such as tamoxifen and aromatase inhibitors have had a profound Impact on the treatment of estrogen receptor positive (ER

Public health relevance
Resistance to hormonal therapies in breast cancer represents a clinically unmet need. Should IGF/Ins blockade enhance the activity of hormonal therapies and reverse or prevent the acquisition of resistance, this could have a major impact. Possible outcomes include co-IGF/hormonal blockade Increasing survival in metastatic breast cancer and increasing the rate of cure in the adjuvant setting.